Investigations of the role of Semaphorin 5A in innate immunity

Semaphorins are a family of membrane-bound and secreted proteins studied extensively in neuronal development, and more recently explored in airway biology and inflammation and in animal models of immune regulation. Activation of signaling pathways involving these proteins is dependent on the binding of semaphorins to their receptors, plexins. Using a protein biomarker discovery platform, we previously described increases in plasma levels of SEMA5A, (6.4- fold change at 1h) and Semaphorin 6B (SEMA6B, 3.3 fold change at 1h) that decrease over 8h following intravenous (IV) endotoxin (LPS) challenge in healthy volunteers (Am J of Respir Crit Care Med 2018; 197: A4749). This is the first reported association of this SEMA5A with acute inflammatory responses and a detailed examination of semaphorins and their receptors in the context of innate immunity is currently lacking. This project aims to investigate the role of SEMA5A in innate immune responses by addressing the specific aims described below.

Specific Aim 1: To determine baseline in situ expression of Semaphorin 5A (SEMA5A).

Current status:
We have conducted preliminary in situ hybridization (ISH) experiments that show that SEMA5A is not expressed in immune cells, but rather epithelial and endothelial cells in the lung. We are currently performing ISH with several different markers to further determine the localization of SEMA5A in the lung. Preliminary ISH data suggest that SEMA5A is expressed by smooth muscle cells, bronchial epithelial cells, and alveolar cells.

Specific Aim 2: To determine whether SEMA5A or SEMA6B loss of function affects the LPS-induced acute inflammatory response.

Current Status: SEMA5A and SEMA6B knockout animals are commercially available and have been obtained. Colonies of these animals have been established. These animals, along with appropriate wild type controls, will be stimulated with endotoxin intra-tracheally and lungs, lung lavage fluid, serum and other organs will be obtained and analyzed for inflammatory cell infiltration, architectural changes, and immune cell phenotypes, as well as changes at the gene expression level. In separate experiments, these animals will also be assessed for survival following endotoxin challenge. Additional gain of function experiments suggest that excess SEMA5A might have opposite effects, namely increased neutrophil recruitment.

Specific Aim 3: To determine the role of SEMA5A and SEMA6B in human lung inflammation.

Current status:
Preliminary experiments suggest that SEMA5A is found in increased levels in lung lavage from patients with acute lung injury. Further confirming this, we have analyzed lavage from patients with various bacterial pneumonias, and patients with ARDS. We have also determined the cellular source of this protein and its potential role in inflammation.

Specific Aim 4: to determine the effect of SEMA5A on neutrophil migration

Current status:
Pre-treatment of neutrophils with SEMA5A leads to changes in neutrophil migration. Neutrophil migration is enhanced in the presence of SEMA5A. Current experiments are focusing on the mechanisms behind this enhanced migration.

No publications are associated with this Annual Report. However, we have published a review on the subject in Frontiers in Immunology.